Third Coast HIV-Related Cardiovascular and Sleep Disorders K12 Career Development Program

PROGRAM SUMMARY/ABSTRACT
The Third Coast HIV-related Cardiovascular and Sleep Disorders K12 Career Development Program (TC-
CSK12) is a collaboration between the University of Chicago and Northwestern University that will
establish an interdisciplinary pathway to academic productivity for the next generation of physician and
non-physician junior faculty scientists. Mentored by world-class experts, tailored and individualized
curricula most relevant to productivity provided by both program mentors and resource faculty will support
trainees' projects in two high priority research topic areas in HIV-related – cardiovascular disease and
sleep disorders. These two areas will be further stratified into one of four high impact pathways: heart
failure; coronary artery and other vascular disease; sleep disordered breathing; and circadian disruption
and stress. Trainees' mentored research will be foundational for career-long intellectual growth and
academic advancement, and will be supported by resources for collaborative scholarship and discovery
across a range of scientific disciplines, methods and concepts. TC-CSK12 will also have scientific
disciplinary clusters: molecular and cellular; genomics, epigenetics and proteomics clinical and
translational; and data science and computational modeling. Didactic and experiential learning across
these clusters will be customized with mentoring for each individual trainee's pathway. The research itself,
along with mentoring and cross-disciplinary curricula, will enable new insights into the complex
mechanisms underlying HIV related cardiovascular and sleep disorders (HIV-CS) and careers that will
produce major advances in diagnosis, treatment, monitoring and/or prevention of the disorders targeted in
our pathways. The ultimate objective of our program is to identify, inspire, and support development of
independent, NHLBI-funded investigators in HIV research with strong and broad methodological and
conceptual skills as well as collaboration expertise/enthusiasm. Training, mentorship and career
development strategies will draw upon several successful programs many of which are already shared
across NU and UC and set a strong precedent for TC-CSK12: the integrated Third Coast Center for AIDS
Research, two successful and collaborative CTSAs, and other successful K12 and NIH-funded training
programs at the University of Chicago and Northwestern University including a collaboratively held T32 in
sleep for the past 20 years. In addition to collaboration-building infrastructure that brings faculty into the
study and mentorship of HIV-CS. Trainees and their mentors will draw on our diverse NIH-funded,
community-based research cohorts of HIV-infected, -affected, and at-risk persons in one of the largest
domestic HIV epicenters in the United States. This ensures that research and training supported by this
program will positively impact the most vulnerable populations in years to come as we move towards
elimination of both HIV and its complications not yet solved by antiretroviral therapy (ART).

Public health relevance
PROGRAM NARRATIVE The Third Coast HIV-related Cardiovascular and Sleep Disorders K12 Career Development Program (TC- CSK12) is a collaboration between the University of Chicago and Northwestern University that will establish mentorship for junior faculty scientists. Mentored by experienced researchers, tailored and individualized curricula most relevant to productivity provided by both program mentors and resource faculty will support trainees' projects in two high priority research topic areas in HIV-related – cardiovascular disease and sleep disorders. These two areas will be further stratified into one of four high impact pathways: heart failure; coronary artery and other vascular disease; sleep disordered breathing; and circadian disruption and stress.